T Cell Receptor Mediated T Cell Activation in Neonatal and Pediatric Sepsis

Sepsis is life-threatening organ dysfunction caused by a dysregulated host response to infection.
children account for half of worldwide sepsis mortality. Neonatal and pediatric sepsis has
different clinical characteristics when compared to adult sepsis – indeed the adult sepsis
definition is not currently applied to children – but limited research has focused on the
immunologic differences in the response to sepsis over age. Herein, we propose to use the natural
development of T cell memory as a natural experimental variable to provide insight into how T
cell memory influences sepsis-associated organ dysfunction. We hypothesize that, in dysregulated
inflammation, hyperactivated APCs overexpress co-ligands that promote T cell receptor (TCR)-
mediated activation of memory T cells, directing aberrant host responses and amplifying innate
immune activity and organ dysfunction in sepsis and other severe inflammatory diseases.
Angiotensin II signaling modulates these interactions. We are uniquely positioned to study T cell
memory responses to sepsis over age – and we posit that the dysregulated T cell-APC interactions
that we have found increase in prevalence and influence in directing the response to sepsis as we
age. Specifically, we hypothesize that the T cell receptor activation threshold is influenced by
sepsis and age – and that this threshold may be a key in understanding sepsis. The principal
investigator has demonstrated that T cell memory responses promote both innate immunity and
organ dysfunction in previous work. The global hypothesis of our work is that, in sepsis, altered
host responses that cause organ dysfunction may be characterized by dysregulated and
dysfunctional interactions between immune cells, primarily driven by memory TCR activation.
We propose herein to use comparisons between human neonates with sepsis and pediatric and
adult sepsis patients to understand how T cell memory and sepsis affect T cell-APC interactions
and TCR activation. We will further pursue work to understand how other circulating factors in
sepsis, specifically components of the renin-angiotensin-aldosterone, are affected by age and
affect TCR-activation. TCR signal response effects on sepsis are not well understood and
represents a clear gap in our understanding of human sepsis pathophysiology – we aim to address
this gap in our current proposal.

Public health relevance
Children account for half of worldwide sepsis mortality but neonatal and pediatric sepsis has different clinical characteristics when compared to adult sepsis. This proposal will focus on immunologic differences in the response to sepsis over age – specifically focusing on effects of sepsis on T cell receptor activation. A portion of this proposal will also investigate the effects of sepsis-induced renin-angiotensin-aldosterone system alterations on sepsis-associated immune responses.